Biogeography of Microbial and Plant-Derived Redox-Active Small Molecules and Combinatorial Effects on Microbial Growth

Biogeography of Microbial and Plant-Derived Redox-Active Small Molecules and Combinatorial Effects
on Microbial Growth
Soil is the source for many antibiotics of clinical relevance and the training ground for the organisms that
both produce and resist them. Engineering and managing microbial communities in human health necessitates an
understanding of the soil environment where these organisms often originate. My lab is working to determine the
combinations of plant and microbial small molecules that microbial communities experience in soils and how this
affects their growth and survival across environments.
It is now evident that antibiotics produced by soil bacteria and their co-occurring microbial neighbors can
shape microbial growth as well as community composition, function, and resilience. However, we do not yet
understand the biogeography of these small molecules, i.e. what combinations of natural antibiotics a microbe
might typically encounter and how this varies from one microbial community to another. In addition, much work
has focused on studying microbe-microbe interactions facilitated by small molecules. Yet, in soils, microbial
consortia often live on plant hosts that release natural products capable of sculpting rather than eliminating the
microbial community. How does this work? While some plant secondary metabolites do inhibit canonical
antibiotic targets (ribosomes, DNA replication, cell wall biosynthesis), many plants also produce low-dose
antimicrobial compounds that use reduction-oxidation (redox) reactions to control microbial communities at their
roots. We suggest i) that root-associated microbial communities offer an experimentally tractable system to test
hypotheses about secondary metabolite biogeography ii) that the production of plant and microbial redox-active
metabolites is an expedient entry point for these studies and iii) that plant-produced redox-active metabolites have
been understudied as features of the soil environment that may offer insights into how microbes have learned to
survive in diverse contexts, including infections.
This proposal outlines my lab’s long-term plan to study the patterning and combinatorial physiological
effects of microbial and plant redox-active compounds on the growth and development of microbial communities.
We will take a two-pronged approach. The first part of our efforts will be aimed at using newly developed screens
to identify redox-active metabolites made natively in soils and determine patterns of (co)production. A second
area of our work will explore the molecular mechanisms by which known redox-active plant metabolites
(coumarins) affect microbes. Iteration between the two approaches will allow us to conduct environmentally
informed experiments that test the effects of co-occurring small molecules on microbial communities. Findings
from this work will inform the development of therapeutics to irradicate microbial infections and provide tools
for the discovery and activation of novel antimicrobial compounds produced by soil organisms.

Public health relevance
PROJECT NARRATIVE Soil-dwelling microbes survive and thrive in a rich milieu of small molecules and figuring out how they do this has implications for understanding their capacity to survive antibiotic assaults in clinical settings. This proposal aims to elucidate patterns of small molecule production across microbial communities and to investigate the physiological effects of plant metabolites, which are understudied features of the small molecule environment in soils. A better understanding of this aspect of microbial life in the wild will help us discover new antibiotics and use the ones that we already have more effectively.